Administrative Core

Administrative Core. This administrative Core will have both scientific and organizational responsibilities. The scientific aspects will be carried out by Dr. Kwiatkowski. He will advise investigators on strategic and technical issues, promote collaboration and contact among projects, monitor the functions and effectiveness of the core facilities, and assess the scientific quality and progress of the work. This will require active interactions with all groups on a regular basis. Any scientific problems or organizational issues that arise will be discussed first with the co-PI, Dr. Cantley. There will also be an Internal Advisory Board composed of senior scientists in the Boston area, who will meet on an ad hoc basis to assist with any scientific or organizational issues. There will also be an External Advisory Board composed of senior scientists from outside Boston. There will be annual all-day meetings at which Project and Core Investigators will present research progress and plans to members of the Internal and External Advisory Board. Organizational aspects of the PPG will be handled by Dr. Kwiatkowski and the Administrative Coordinator, Robyn Naigles. She will organize all interactions among the projects and the cores, including arranging the annual meeting, and deal with all other administrative aspects including preparations of all progress reports and applications related to this PPG.

Public health relevance
RELEVANCE (See instructions): The overall goal of this program project application is to find treatments forthe hamartoma syndromes, and the common cancers in which these same genes (TSCl, TSC2, LKBI, PTEN) are involved. This administrative core sen/es a critical function in the administration and facilitation of this overall research program.